DECREASED CLEARANCE OF CNS AMYLOID-β IN ALZHEIMER’S DISEASE

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. Alzheimer's disease is hypothesized to be caused by A[unreadable] disequilibrium leading to increased A[unreadable] in the CNS. A[unreadable] production and clearance have both been postulated to be the cause of A[unreadable] disequilibrium and are key targets in the development of disease modifying therapeutic agents for Alzheimer's disease.